A new bladder cancer model based on tissue reprogramming and gene targeting

Project Summary: With recent advances in cellular reprogramming and gene editing it became possible to envision new approaches for tissue modeling in normal and disease contexts. Specifically, we propose to use transdifferentiation and gene targeting to generate a novel genetically-engineered model system for studies of human cancer. We recently developed a highly innovative methodology for generating fully functional prostate tissue in renal grafts based on a computational system approach that identifies synergistic specification genes (Talos et al., Nat Commun, 2017). We propose here to apply and expand these methods for modeling human bladder cancer by combining lineage conversion of fibroblasts with tissue recombination assays, advanced computational systems biology algorithms and CRIPSR/Cas9-mediated gene targeting of clinically-relevant mutations. In our preliminary studies, we have shown that fibroblasts can be directly converted into epithelial cells following transient expression of the pluripotency factors in pro-epithelial culture conditions. Moreover, these induced epithelial cells are amenable to further terminal differentiation into bladder tissue in tissue recombination assays in vivo under the inductive force of bladder specific mesenchyme. Based on these preliminary data, we hypothesize that the inherent plasticity of readily-accessible fibroblasts can be exploited to generate bladder epithelia through a combination of key bladder specification genes, reprogramming techniques and tissue recombination assays. Moreover, we hypothesize that the reprogrammed bladder tissue is amenable to malignant transformation through CRISPR-mediated gene targeting. To test this hypothesis and generate a new model of human cancer, we propose to perform (1) Direct conversion of human fibroblasts into bladder epithelium by activation of master regulator genes of normal bladder epithelium, identified by bioinformatic analysis of regulatory genetic networks of bladder or by a candidate gene approach and (2) Modeling human bladder cancer by CRISPR-mediated gene targeting in the reprogrammed tissue of tumor suppressors and oncogenes relevant for human disease. Our studies will provide novel insights into the mechanisms underlying bladder tumorigenesis and a novel platform for drug screening and for discovery of patient-specific early prognostic biomarkers.

Public health relevance
Project Narrative: Developing informative and predictive model systems for rapid assessment of recurrent genomic alterations uncovered by whole genome sequencing of human cancer remains a major challenge in the Big Data era. This is particularly valid for human bladder cancer where current models are limited. Our studies aim at generating a novel model system that would enable precise genetic editing of reprogrammed human bladder tissue in vivo. We propose here to grow de novo human bladder tissue in rodents and use it as a platform for mechanistic studies of cancer initiation and early progression that are inaccessible for large-scale mutational studies with the current models.